Impact of Prescription Caps on Health Outcomes in People Infected with HIV

PROJECT SUMMARY
The availability of contemporary antiretroviral therapy (ART) has changed infection into a manageable chronic
disease for people living with HIV (PLWH) who have access to and are adherent with treatment. Adherence to
medications for either HIV or major medical and mental health conditions is frequently suboptimal even for
those with prescription coverage. Those with multiple, chronic diseases face compounded adverse
consequences when they fail to take necessary medications. Prescription drug cost containment efforts may
undermine long-term adherence with implications for adverse health consequences, though the body of
literature is fairly limited and dated particularly in the context of HIV. Despite this understanding, plan
managers, particularly states' Medicaid programs, continue to implement restrictions through a variety of
utilization management strategies such as prescription cap policies, limiting the number of medications
covered per month. In our recent analyses of persistence rates for ART, renin angiotensin antagonists, and
metformin in HIV+ versus HIV- Medicaid enrollees, we noted lower persistence in states with restrictive
prescription caps. Our long-term research goal is to ensure effective medication utilization management
policies which balance budget priorities with population quality and quantity of life. The objective of this
application is to evaluate the how Medicaid prescription cap policies impact the health of persons with HIV and
public expenditures. We propose to study national enrollment, prescription, hospital, and medical claims data
across multiple years, exploiting the adoption of, changes to, and redaction of medication caps. In particular,
we will study Medicaid and Medicare enrollees with HIV to illustrate how state-based policies contribute to
outcomes in this particularly vulnerable population. These natural experiments will offer significant insights into
the impact of restrictive prescription policies on patients' health outcomes and public budgets. The central
hypothesis is that prescription caps will lead patients with HIV to greater rates of HIV and non-HIV chronic
disease complications, leading to additional costs. The rationale for this hypothesis is that people with HIV
frequently have co-occurring conditions likely to require several prescriptions simultaneously and capping the
number they receive each month may undermine their health. We have already made a large investment in
and established extensive experience with Medicaid claims data from 14 high HIV prevalence states (2001-
2012). Through the addition of three more years of Medicaid claims (2013-2015) and the inclusion of Medicare
Parts A, B and D claims from ~300,000 HIV infected beneficiaries across the country from 2006-2015, we will
have a comprehensive infrastructure from which we can describe the impact of prescription caps on ART
adherence, evaluate the impact of prescription cap policies on adherence to medications for major comorbid
conditions (i.e., diabetes, cardiovascular disease, serious mental illness), and estimate the potentially
avoidable health and economic effects of ART and chronic disease medication adherence.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because medications are vital for long term management of human immunodeficiency virus (HIV) and medical and mental health conditions which are common in people with HIV. Prescription cap policies imposed on our most vulnerable populations, such as low income Medicaid beneficiaries, may force them to go without treatments or decide between which treatments to use. Ultimately, these decisions can have adverse effects on their health and the responsible allocation of public funds.